Lung Dysbiosis and Increased Host Susceptibility to Respiratory Pathogens

Lower airway infections are a significant burden for Veterans. Current therapies commonly involve the use of
broad-spectrum antibiotics that lack pathogen specificity and decimates microbial ecology in the human body.
The discovery of lung microbiota with the use of next-generation sequencing identified a diverse lower airway
microbial community. Our group has shown that the enrichment of the lung microbiota with human oral
commensals, such as Streptococcus, Veillonella, and Prevotella, is a hallmark of lower airway dysbiosis
associated with increased inflammation and immune exhaustion markers. This dysbiotic signature can be seen
in healthy subjects and occurs with higher frequency with chronic inflammatory lung disease such as Chronic
Obstructive Pulmonary Disease and lung cancer. In this Veterans Affairs BLR&D CDA2 resubmission, I seek to
demonstrate how chronic lung dysbiosis is associated with increased pathogen susceptibility by modulation of
the lung immune tone through anaerobic microbial metabolites such as short-chain fatty acids (SCFAs) in a pre-
clinical murine model. In our publications, lower airway dysbiosis is associated with increased SCFAs, blunted
T cell response to pathogen associated molecular patterns, and increased expression of exhaustion markers
and Tregs. My mouse model of induced chronic lower airway dysbiosis and in my preliminary data show
increased expression of exhaustion pathways, PD1+ T cells and Tregs in the lung, and increased respiratory
pathogen susceptibility in the form of murine mortality and pathogen recovery.
The proposed study will use my chronic lung dysbiosis murine model to define the molecular mechanisms
leading to the host susceptibility to respiratory pathogens. In Aim 1, I will identify microbiota signatures with the
use of metatranscriptome and metabolome approaches present in the chronic murine lower dysbiotic airway,
including measurement of SCFA levels and bacterial functions affecting them. I will also test whether SCFAs
are sufficient to alter host pathogen susceptibility. In Aim 2, I will identify and test host functional phenotypes of
immune exhaustion in my chronic lower airway dysbiosis murine model using fluorescent-activated cell sorting,
single-cell RNA-Seq, and assessment of T cell subpopulation function following anti-CD3/CD28 activation. I will
also evaluate the role of immune exhaustion on pathogen susceptibility by using checkpoint inhibition during
chronic dysbiosis to assess if anti-PD-1 will restore pathogen response.
These studies will be performed under the mentorship of Drs. Leopoldo Segal, Xue-Ru Wu, Jun-Chieh Tsay
and Jeffrey Weiser. Dr. Segal is my primary mentor and a VA affiliated researcher. He is an expert in systems
biology approaches utilizing next-generation sequencing to evaluate airway disease. His expertise in
bioinformatic approaches to translational research places him at the forefront of lower airway multi-omic
research. My co-mentor is Dr. Xue-Ru Wu who is an expert on urothelial disease and built a career in
assessing pathogenic mechanisms that will be highly relevant for my mentorship. Although his expertise is
focused on the urothelial tract, his training in experimental design, assessment of molecular mechanisms, and
use of murine models will be critical for my scientific training. Dr. Jun-Chieh Tsay is a VA physician scientist
with a research focus on lung inflammation in lung cancer. As a co-mentor, he will be a significant resource to
assess host inflammation, transcriptomic pathway analysis, and for my career with the VA. In addition, I
recruited Dr. Weiser as a co-mentor for his expertise as an international expert in airway mucosal immunity
and infection. The mentors and their laboratories, together with the expertise of Veterans Affairs and NYU core
laboratories, will provide the optimal setting for the development of my research career. The BLR&D CDA2 will
provide the support for my training in the methodologies and techniques necessary to complete the proposed
experiments. This proposal will provide the fundamental mechanistic understanding to expand to future
investigations involving human cohorts.

Public health relevance
Lower airway dysbiosis characterized by the enrichment of the lungs with oral commensals is a poorly understood phenomenon, but a common event that increases in the diseased lung. Veterans with lung dysbiosis may be at-risk for increased pathogen susceptibility and infection. Chronic dysbiosis is associated with increased lung PD1+ T cells and Tregs which may mediate the poor immune response to respiratory pathogens, something that I will study using a pre-clinical murine model in this project. I will use next-generation sequencing with multi- omic bioinformatics and measurement of microbial metabolites to identify functional host-microbiota signatures in chronic dysbiosis associated with increased pathogen susceptibility. I will evaluate the mechanisms involved in determining the altered lower airway immunity against respiratory pathogens induced by chronic dysbiosis. My proposal is relevant for the veteran population as pneumonia is one of the main causes for VA hospital admission, thus identification of modifiable targets is a priority.